Developmental Research Program

The Developmental Research Program is a major focus for the SPORE because this mechanism provides a continuous flow of new ideas, projects and investigators to stimulate translational breast cancer research in the context of the SPORE. It provides the opportunity to encourage and facilitate the development of new directions, methodologies, and collaboration. It is also a major vehicle to allow the SPORE broad access to investigators at The Johns Hopkins University and Howard University in Washington, D.C. Its importance is signaled by the fact that about 8% of the direct costs of the SPORE are invested in the Developmental Research Program. A two-tiered review and approval process for pilot projects is used analogous to that employed by the National Institutes of Health. A Scientific Review Committee led by Bert Vogelstein, M.D. reviews proposals for their scientific merit. The Breast Cancer SPORE Steering Committee makes final funding decisions using the scientific review from Dr. Vogelstein's review committee and programmatic priorities to guide its selections. The SPORE Principal Investigator, Dr. Davidson, serves as administrative coordinator with able assistance from the SPORE coordinator, Cindy Morin.